The impact of Medicaid expansion on the rural mortality penalty in the United States

Project Summary
Rural areas in the United States (U.S.) have exhibited higher mortality rates than urban areas since the late 1990s, a
pattern known as the rural mortality penalty. Recent research has found that the rural mortality penalty continues growing
due to mortality associated with preventable causes (metabolic and cardiovascular causes, alcohol use, and mental health).
The expansion of Medicaid adopted by many states in the U.S. had the potential to reduce death due to these and other
causes by facilitating access to healthcare to people who were not eligible under previous eligibility thresholds. While
some state in the nation adopted this expansion, a process that started in 2014, others rejected it. While the
adoption/rejection of this expansion is well-documented, little is known about the role the adoption of this policy at the
state level impacted well-established demographic phenomenon such as the rural mortality penalty. This project requests
access to restricted data to produce mortality rates for the population aged 19-64, by sex and by race/ethnicity to conduct a
novel analysis of the differences observed in the rural mortality penalty employing a difference-in-difference design. The
project evaluate whether the Medicaid expansion impacted the rural mortality penalty emphasizing the overall population,
and disparities by sex and race/ethnicity. The project will also be the first to explore whether the COVID-19 pandemic
impacted rural/urban mortality dynamics based on state-level adoption of the expansion of Medicaid by 2020. The
analytic approach will combine formal and mathematical demographic methods with novel statistical models to evaluate
the impact of the expansion of Medicaid in rural/urban mortality dynamics. Findings from this project will illustrate the
role that state-level policies have in shaping diverging or congruent trajectories in mortality and in the face of the ongoing
COVID-19 pandemic.

Public health relevance
Project Narrative The purpose of this project is to (1) estimate age-specific mortality rates for rural and urban areas by state, Medicaid expansion status, sex, and race/ethnicity (2) to study the effect of Medicaid expansion on rural mortality penalty using data from 1999 until 2019, and (3) to determine whether states that expanded Medicaid witnessed differential mortality increases during the first two years of the COVID-19 pandemic (2020 and 2021). This project will use restricted NCHS mortality data, census population estimates, rural-urban continuum codes, standardization techniques, and regression- based research design to examine the effect of Medicaid expansion on rural and urban age-specific mortality rates for the population aged 19-64, by sex, and by race/ethnicity. The project will also evaluate the disparities in mortality observed in the first two years of the COVID-19 pandemic at the intersection of residential context and state policies.